Attentive knowledge device for visual assistance

The latest Artificial Intelligence (A.I.) smartphone apps have been a game changer for many persons with
visual impairment. Yet, the current workflow of these apps remains cumbersome: snap a picture, ask a
question, wait for a few seconds, listen to an (often verbose) answer; repeat. Could a workflow that is more
natural, goal-driven, and more synergistic with a visually-impaired person be created? The basic tenet of this
proposal is to leverage A.I. in a new way: Instead of being front and center, the A.I. will operate mostly in the
background. Instead of only answering user queries, it will also be informed by a collection of machine vision
algorithms that collect rich real-time visual information, from 4 cameras mounted on smart eyeglasses with an
ultra-wide 270o field of view. The machine vision algorithms will run 100x faster than the A.I. can, to handle the
dynamics of the world and of the moving user. The role for the A.I., then, will be to leverage its world
knowledge to combine, unbeknownst to the user, contextual situation awareness from real-time vision with
high-level tasks and goals specified verbally by the user. Our central working hypothesis is that the A.I. will be
able to better assist its user by proactively integrating what the glasses have seen with what the user actually
wants. Our team combines expertise in a) computational neuroscience, machine vision, and A.I. (PI Itti), b)
micro- electronics and machine vision hardware (co-PI Narayanan), c) human factors, lived experience focus
groups, and participant recruiting (GetBraille consultants), d) wearable electronics design and fabrication
(Siliconscapes consultant), and e) lived experience partners and participants at the National Federation of the
Blind and several other local chapters and communities. In the R61 phase, we aim to: 1) engage our lived
experience partners in selecting the most useful algorithms for visual attention, object detection, 3D depth
estimation, scene recognition, spatial navigation and mapping, and hand/face/body tracking algorithms. These
will provide real-time situation awareness that runs in the glasses (no cloud servers), and is non-intrusive to the
user; 2) develop visual-assistive large language models (LLMs) to digest and leverage the machine vision
results and help the user achieve an unbounded range of tasks; 3) implement and accelerate the real-time
machine vision algorithms onto Field-Programmable Gate Array (FPGA) custom hardware processors to
achieve high energy efficiency in a small form-factor. In the R33 phase, we will collaborate with our lived
experience partners to create and test affordable, intuitive, and useful smart glasses that can be broadly
disseminated ($399; compare to $4,250 Orcam MyEye 3 Pro). We aim to 1) develop miniature, low-power,
low-cost implementations of the glasses, 2) engage our lived experience partners in developing a user
interface that works best for them, 3) conduct a user study with 5 groups of 50 PVI participants, each R33 year,
covering a range of tasks from grocery shopping to cooking to working in a team, 4) address issues of privacy,
security, social acceptance, and liability, through focus-groups with experts, the PVI community, and students.

Public health relevance
This research is relevant to public health as it will, guided by the visually impaired community, develop new algorithms and a device aimed to empower visually impaired users in a broad range of tasks. A core research question is how to extract actionable intelligence and situation awareness, on device (no cloud), from vast amounts of real-time machine vision data, which will be answered by combining machine vision with large language models. The expected outcome is an affordable device that is more responsive, agile, and on-task than the current state of the art, such as a smartphone connecting to a large-language model in the cloud.